Novel high-throughput approaches to discover and dissect human transcriptional protein interactions

PROJECT SUMMARY/ABSTRACT
Understanding transcription factors in human cells is essential for insights into development, health, and disease.
However, our understanding of the protein-protein interactions driving transcriptional regulation remains
incomplete. While high-throughput screens have identified hundreds of effector domains within transcription
factors, their underlying molecular mechanisms remain largely unknown. We lack a comprehensive molecular
understanding of which of the >1000 effector domains interact with which of the >700 cofactors, the specificity
of these interactions, and how this specificity quantitatively influences gene regulation. This information is crucial
for understanding basic principles of transcription and could also stimulate development of novel therapeutics
capable of targeting these biologically essential but historically undruggable interactions.
Current high-throughput interaction screens, capable of measuring many-by-many candidate interactors,
employ transcription as a readout (e.g. two-hybrid approaches), making them ill-suited for studying transcription-
associated networks. Furthermore, most methods for generating quantitative measurements of direct
interactions (e.g. Kds, kons, koffs) are low-throughput and labor-intensive, involving extensive cloning, purification,
and testing, which can take months if not years, severely limiting our ability to quantify the direct connections
within these extensive protein-protein interaction networks. As a result, we have a very limited picture of how
these interactions contribute to transcription.
Here we will overcome these challenges by leveraging our expertise in development of high-throughput
approaches, biophysics, and quantitative cell biology to first, develop a novel cell-based technology to generate
a comprehensive matrix of 106 proximities between human transcriptional effector domains and the cofactors
they recruit to regulate transcription (Aim 1). Next, we will determine the degree of specificity between these
interactions using a high-throughput microfluidic technology we recently developed to quantitively measure the
strength and timing of direct interactions (e.g. kon, koff, Kd) (Aim 2). Last, we will move beyond simple explanations
of our observations towards predictive models to quantify how the specificity of interactions determines the
strength and timing of gene regulation (Aim 3). The proposed research will generate a novel technology for
large-scale mapping of many-by-many protein interactions with a wide dynamic range that will have immediate
broad application to other biological systems beyond transcription (e.g. cell signaling networks). In addition to
this technological innovation, by mapping the proximity network between effector domains and cofactors,
quantifying their direct interactions, and linking these interaction specificities, strengths, and kinetics to gene
regulatory dynamics, we will reveal new principles of transcription factor-mediated gene regulation.

Public health relevance
PROJECT NARRATIVE Gene regulation is fundamental to biology and a predictive understanding of how protein specificity impacts transcription has far-reaching impacts on both medicine and technology. While we know where transcription factors bind in the human genome, we still do not have a predictive understanding of what happens after DNA binding; we do not know which cofactors they bind and what effect that has on gene expression. Here, we will develop and deploy a suite of novel high-throughput technologies designed to identify and understand how protein-protein interactions between transcription factors and cofactors specify transcription, generating critical new tools and quantitative data that could be used for next-generation drug discovery.